Representational geometry: evaluating brain-computational models with neural activity data

Project Summary
Computational neuroscience has entered a new era of greatly increased capability to record neuronal activity and
to construct large-scale computational models. The challenge before us is to connect theory and experiment by
testing and comparing complex brain-computational models with massive measurements of neural activity. Con-
necting experimental results to computational models is critical for deepening our understanding of the neural
circuit computations that collectively give rise to perception, cognition, and behavior, basic brain functions with
fundamental clinical implications. This project would launch a close collaboration between theorists and experi-
mentalists to develop a rigorous and comprehensive methodology for evaluation and comparison of our new big
models with our new big data. A central concept that has gained momentum over the past two decades is the
concept of representational geometry. The representational geometry is the geometry of the points or trajectories
in the multivariate neural population response space that are thought to represent the contents of brain compu-
tations. Although a variety of estimators of representational distance have been proposed previously, none of
them are well-suited for neural activity data. Adequate estimation of the representational geometry from neural
response data requires carefully accounting for the marginal Poisson distribution of the noise, noise correlations,
the context of the neural manifold, and biases caused by electrode sampling as well as by the sensitivity of es-
timators to noise displacements. We will address key conceptual and technical challenges and conduct the first
large-scale, objective evaluation of a broad range of options for evaluating representational models. Aim 1 is to
develop a general-purpose methodology for testing theories implemented in neural network models with modern
neurophysiological data. The methodology evaluates and inferentially compares models on the basis of their pre-
dictions of neural representational geometries, and encompasses encoding models and representational similarity
analysis, methods that allow different levels of flexibility in fitting model representations to neural data. Aim 2 is to
validate the methodology developed in Aim 1 in the context of neuroscientific applications, where computational
theories are evaluated with neurophysiological data. On the one hand, we will use model-based simulations and
sub-sampling of neural recording data sets to validate the inferential methodology in scenarios where ground truth
is known. On the other hand, we will seek empirical answers to exciting theoretical questions in the domains of
vision and spatial navigation. Overall, the project will build a comprehensive methodology for linking theory to
experiment in computational neuroscience in the new era of neural network models and modern neuroscience
methods. The methodology involves formal inferential comparisons of brain-computational models that implement
alternative theories. The project also launches the ongoing open-source development of this critical methodology
through a series of workshops for theorists and experimentalists.

Public health relevance
Project Narrative The modern neuroscience revolution and the neural network model revolution have disrupted computational neuro- science in complementary ways, offering exciting new possibilities, but also requiring a reinvention of our empirical methodology. This project would develop, validate, and disseminate a general methodology and open-source toolbox for inferential model comparison on the basis of model predictions of brain-representational geometries, connecting theory and experiment in this new era. The research will deepen our understanding of the neural circuit computations that underlie our perception, cognition, and behavior, which will have substantial long-term implications for the treatment of brain disorders.